Renal Disease

PROJECT SUMMARY/ABSTRACT
This application is the competitive renewal of the “Renal Disease” Training Program at Washington
University School of Medicine. The program, which began in 1975, has a strong record of training postdoctoral
fellows who are committed to careers in nephrology research. The current application, which seeks support for
three MD, MD/PhD or PhD postdoctoral trainees per year, incorporates a number of new programmatic
features developed to enhance the training mission. The goal of the training program is to develop independent
scientists who will ultimately work to improve outcomes of patients suffering from kidney disease. The Program
accepts trainees from an expanded pool of outstanding applicants and benefits from close relationships to the
Institute of Public Health, the Institute of Clinical and Translational Sciences, the Physician Scientist Training
Program and the Division of Biology and Biomedical Sciences. Establishment of a Diversity Recruitment
Committee is a new feature that will help to increase the number of under-represented minority trainees in the
program. Also new to this competitive renewal is the offering of a clinical research training track encompassing
translational research, public health and clinical effectiveness, which complements our basic science track.
Trainees will benefit from extensive didactic offerings leading either to a Master of Science in Clinical
Investigation or a Master of Population Health Sciences degree. The centerpiece of either track remains an
intense mentored research experience. Trainees are mentored by a committed primary faculty mentor, in
collaboration with their mentoring committee. The talented group of 28 well-funded preceptors are now
organized into four thematic areas - Kidney Injury and Repair, Pathogen-Host and Genomics, Epithelial Biology
and Clinical/Translational. These preceptors are a major strength of this grant. The uniquely collaborative
environment at WUSM provides an ideal setting for the professional development of the trainees. Hands on
workshops, research seminars and programs in the Responsible Conduct of Research complement the four
thematic areas.

Public health relevance
PROJECT NARRATIVE: The Renal Disease Training Program has the singular goal of training basic and clinical investigators to be successful and qualified kidney scientists of the future. Through this program, M.D., Ph.D. and M.D./Ph.D. postdoctoral trainees are mentored by established investigators who are actively involved in high-impact cutting edge kidney-oriented research.